DEVELOPING SUPPLEMENTAL STRATEGIES TO ENHANCE MS APPLICATIONS

Five projects that address limitations of the chemistry and chemical separations aspects of analytical mass spectrometry for glycoconjugates have been proposed. These include (a) a microbore porous graphite column HPLC-MS interface for separation and direct introduction of carbohydrates into the mass spectrometer; (b) an investigation of carbohydrate reducing-end rhodamine derivatives for improved CID spectra, and for cell surface lectins for FACS (fluorescence assisted cell sorter) analysis; (d) the development of strategies to locate glycoconjugate O-sulfate groups using deuteriomethyl labeling and CID mass spectrometry; and (e) an improvement in strategies to separately release N- and O-linked glycan chains from glycoproteins.